Informatics tools for identification, prioritization and clinical application of neoantigens

Project Summary/Abstract (from parent award: U01 CA248235 as per instructions) Somatic mutations in cancer cells lead to the production of neoantigens: patient- and tumor-specific peptides that are capable of inducing T cell recognition. Recent clinical trials have established that, when introduced in a vaccine, these neoantigens can stimulate anti-tumor immune responses. The path to producing such a personalized vaccine begins with sequencing a patient’s tumor, identifying candidate somatic mutations and then computationally predicting which neoepitopes will be most effective at stimulating a T-cell response. This prediction step should ideally assess a complex interplay of factors, including the type of somatic mutation, the patient’s class I and II HLA alleles, peptide processing, peptide transport, peptide-MHC binding and many co- factors of immune recognition and signaling. The best current approaches focus almost entirely on a single factor (peptide-MHC binding) and have only a 16-43% success rate in predicting immunogenic peptides. To address this challenge we will develop pVACtools, an informatics toolkit for comprehensive identification, characterization, and clinical application of neoantigens. This tool will be the first to support all major neoepitope sources including insertions, deletions, transcript isoforms, gene fusions, peptides from normally non-coding regions, and B cell or T cell rearrangements (BCRs/TCRs). We will also integrate analysis of Class I and II peptide-MHC binding. All tools will be developed to support foundational pre-clinical work in animal models of immunotherapy. Furthermore, we will test several specific hypotheses relating to new predictors of immunogenicity. To elucidate these factors and enhance prioritization of neoantigens we will create the first open access database of experimentally and clinically validated neoantigens. Using these data we will address the question of what peptide-intrinsic and patient-specific features determine the therapeutic potential of a neoantigen. To validate their translational potential, we will apply our neoantigen tools to clinical trials involving checkpoint blockade drugs and personalized cancer vaccines. We will develop a visualization interface that facilitates clinical review and selection of neoantigen candidates for several vaccine delivery platforms. These tools will be used to perform analysis of >200 cases from ongoing vaccine trials to evaluate their performance and address key outstanding immunobiology questions including: (a) the importance of particular neoantigen sources in specific cancer types, (b) the importance of accurately determining HLA mutation/expression, (c) the significance of having both MHC class I and II restricted peptides in a vaccine, (d) how to identify specific neoepitope/TCR pairings, and (e) how neoantigens contribute to mechanisms of resistance to immunotherapies. These tools will thus enable fundamental studies of T cell biology, lead to more effective personalized cancer vaccine designs, and support better prediction of response to checkpoint blockade therapy. Finally, based on these experiences and in collaboration with our team of clinical vaccine trial leaders, we will develop detailed guidelines and training materials for neoantigen analysis.

Public health relevance
There are now several strategies to leverage tumor specific antigens that arise from protein coding somatic mutations as therapeutic targets including checkpoint blockade therapy, personalized cancer vaccines and T cell therapies. Use of TCR mimic (TCRm) antibodies to target neoantigens, therefore bypassing the need to elicit or engineer a responsive T cell would have some advantages over these approaches. In this administrative supplement submission we propose a collaboration between an Informatics Technology for Cancer Research (ITCR) funded team at Washington University (WASHU) who have developed pVACtools for neoantigen characterization and an Innovative Molecular Analysis Technologies (IMAT) funded team at University of Texas at Arlington (UTA) who have developed an approach for development of TCRms and the SANE sensor technology for sensitive experimental evaluation of their performance.